Project MultiNav: A gamified multisensory training and navigation system for blind and visually impaired people

Project Summary
Although there has been decades of assisƟve technology (AT) development, navigaƟon‐related challenges remain one of
the most signiﬁcant obstacles to independence and overall quality of life for blind and visually impaired (BVI) people. The
starƟng point for this research is the view that most navigaƟon challenges experienced by BVI travelers are not due to
vision loss but caused by insuﬃcient informaƟon provided by current navigaƟon technologies. NavigaƟon is a conƟnuous
endeavor involving route planning, wayﬁnding, environmental interpretaƟon and monitoring, and real‐Ɵme movement,
but exisƟng AT soluƟons address these aspects in a fragmented way that signiﬁcantly limits eﬀecƟve spaƟal learning and
navigaƟon. This fragmented approach focuses on isolated tasks (pre‐journey learning vs. in‐situ navigaƟon), segregated
informaƟon (routes vs. maps), speciﬁc modaliƟes (language vs. hapƟc), and siloed technology development (digital apps
vs. physical tacƟle maps). This two‐phase R61/R33 project aims to break down silos characterizing decades‐long AT
development by developing an integrated mulƟsensory navigaƟon soluƟon, called MulƟNav, which converges pre‐journey
map learning with in‐situ navigaƟon assistance, wrapped in a learnable and usable smartphone applicaƟon with strong
pathways to translaƟon. To do so, MulƟNav advances the state of the art for mulƟsensory access idenƟﬁcaƟon through
development of the ﬁrst user‐centered design guidelines specifying the key informaƟon/modality (I/M) pairings needed
to support the highest probability navigaƟon tasks across the complete trip. UƟlizing these I/M pairings, the MulƟNav app's
mulƟsensory mapping system provides users with route and environmental overviews for use in both pre‐journey
exploraƟon and during real‐Ɵme travel, enabling BVI people to obtain a level of environmental access, navigaƟonal
assistance, and spaƟal learning capabiliƟes that are simply not possible from current navigaƟon AT soluƟons. A signiﬁcant
innovaƟon of MulƟNav's approach is that route guidance and map overview informaƟon are coupled with a unique
exploraƟon modes that enables BVI users to learn the real‐world environmental features necessary for safe street crossing
(e.g., intersecƟon geometry, presence of medians, locaƟons of accessible pedestrian signals), as well as a traﬃc view mode
that provides mulƟsensory Ɵme‐of‐day traﬃc data to enable users to hear and feel how a crossing will be navigated in
advance. These features are introduced to users in a gamiﬁed learning mode such that the user interface can be learned,
understood, and uƟlized long‐term via engaging navigaƟon scenarios. As a result, MulƟNav's user‐driven inclusive design
approach is expected to solve high‐probability navigaƟon challenges with tractable and measurable outcomes that will
signiﬁcantly improve BVI mobility, independence, and overall quality of life as a sustainable plaƞorm with widespread
adopƟon.

Public health relevance
PROJECT NARRATIVE This project aims to solve the decades‐long blind and visually impaired (BVI) navigaƟon problem by disrupƟng the all‐too‐ common tendency to develop for isolated trip segments, segregated navigaƟon tasks, and singular sensory modaliƟes (most oŌen through natural language) that has perpetuated the assisƟve technology status quo. To do so, we study and implement MulƟNav, a novel mulƟsensory soluƟon that combines pre‐journey map learning with in‐situ navigaƟon assistance, wrapped in a learnable and usable smartphone applicaƟon with strong pathways to translaƟon. Our user‐driven inclusive design approach is expected to solve high‐probability navigaƟon challenges with tractable and measurable outcomes that will improve BVI mobility, independence, and overall quality of life as a sustainable plaƞorm with widespread adopƟon.